QUANTITATION OF HEPATIC GLYCOGENOLYSIS AND GLUCONEOGENESIS DURING FASTING

The focus of the study is to determine the relative contributions of hepatic glycogenolysis and gluconeogenesis to glucose production during the first 12-14 hours of fasting. Magnetic resonance imaging and spectroscopy in combination with glucose turnover techniques will be used in the study.